Administrative, Leadership Development and Advocacy Core

CORE A: ABSTRACT
The SPORE in Prostate Cancer brings together a highly motivated multidisciplinary team of investigators from
Northwestern University and the University of Chicago, with contributions from NorthShore University
HealthSystem (UC affiliate). The team includes laboratory scientists, urologists, medical oncologists,
pathologists, biostatisticians and bioinformaticians, all of whom are dedicated to conducting state-of-the-art
translational research to develop and test interventions that improve the outcome of patients diagnosed with
prostate cancer.
The Administrative, Leadership Development and Advocacy Core has the following Specific Aims:
Specific Aim 1: To provide integration within the SPORE, and with the Robert H. Lurie Comprehensive Cancer
Center and the University of Chicago Comprehensive Cancer Center
Specific Aim 2: To provide strong oversight of research projects and cores as well as financial oversight through
planning and evaluation activities
Specific Aim 3: To oversee the Developmental Research (DRP) and Career Enhancement (CEP) Programs of
the SPORE to encourage investigators to conduct translational prostate cancer research
Specific Aim 4: To lead an advocacy group and diversity education initiatives in the community
Specific Aim 5: To train the next generation of leaders in prostate cancer research
Specific Aim 6: To facilitate collaborations and integration with NIH and other nationally funded programs such
as the U54 CA203000 (The Chicago Collaborative to Promote and Advance Cancer Health Equity), Department
of Defense and Prostate Cancer Foundation.

Public health relevance
CORE A: NARRATIVE The SPORE Administrative, Leadership Development and Advocacy (Admin) Core provides integration and strong leadership and coordinates oversight of projects and cores to ensure that scientific objectives are accomplished such that the SPORE can have the greatest impact on patients with prostate cancer.